University of Michigan Data Coordinating Center for the Diabetic Foot Consortium

Diabetes-related foot ulcers (DFUs) are prevalent and devastating complications of diabetes, with few
FDA-approved therapies. The Diabetic Foot Consortium (DFC) was established in 2018 as the first multi-site
US clinical research effort to elucidate biomarkers that promote DFU healing and prevent recurrence. The
multiplicity and complexity of known factors contributing to poor outcomes require the diversity of experience
and expertise of the four DFC clinical research units (CRUs), the biomarker analysis units (BAUs), and the
University of Michigan (UM) data coordinating center (DCC) to achieve the scientific objectives of the DFC.
The DCC brings over 23 years of experience in statistical and operational leadership of complex
studies and networks, leveraging specific experience in diabetes complications and co-morbidity modeling,
design and analysis of chronic diseases, biomarker discovery and validation, and FDA collaborations. The
DCC’s leadership in these areas complements the clinical and laboratory expertise of the DFC. Together we
will identify important and reliable biomarkers that predict DFU healing and recurrence and study the
association of patient and physician characteristics with good DFU outcomes. In our first 3 years, the DCC has
built successful and durable partnerships with CRU and BAU investigators and NIDDK scientists to implement
two biomarker validation studies and a biorepository study that collects biospecimens for future research. We
will continue this partnership to complete these complex studies and finalize a platform study in patients with
open DFUs that will support future biomarker studies, as well further our knowledge of the impact of standard
of care therapies and social determinants of health on DFU outcomes. These activities will lay the foundation
for future trials leading to better care and health outcomes for patients with DFUs.
We will accomplish these goals by: 1) providing tailored infrastructure and services to ensure seamless
administration and operations for all DFC studies and facilitate effective communication among DFC
stakeholders; 2) ensuring the collection of timely, accurate and reproducible data and high-quality
biospecimens and maximizing adherence to study protocols by providing expert statistical design, efficient
database architecture, and effective study coordination; 3) applying state-of-the-art bioinformatics and
statistical methods to analyze biomarker qualification, to detect important patient characteristics associated
with good clinical outcomes, and to identify testable hypotheses to guide care for subpopulations of patients
with DFUs. Completion of these aims by a highly experienced and accomplished UM DCC will result in
translation of the validated biomarkers from bench to bedside, and improvements in standard of care based on
comprehensive patient, foot ulcer and treatment data. Collaboration among the CRUs, BAUs, satellite sites,
ancillary study investigators, NIDDK and DCC will maximize the scientific and clinical impact of the Consortium
in this complex and challenging therapeutic area.

Public health relevance
The Diabetic Foot Consortium aims to validate biomarkers that promote healing and prevent recurrence of diabetic foot ulcers and leverage their growing database of patient, wound, therapies and biomarker characteristics to advance standard care. Proper design of biomarker validation studies and analyses using advanced machine learning methods are critical to accomplish these goals. With more than 23 years of experience, the University of Michigan data coordinating center will continue to apply cutting-edge statistical and operational methods to these studies, maximizing the clinical impact of the consortium in this complex and challenging therapeutic area.